Structural Racism, Resilience, and Premature Cognitive Aging in End-Stage Renal Disease - Revision - 5

ABSTRACT
Only 13% of the 780,000 adults living with end-stage renal disease (ESRD) have normal cognitive function. We
found that 14.0% of ESRD patients aged 35-49 experience severe cognitive impairment and 2.9% have a co-
occurring functional dependence suggestive of Alzheimer’s disease and related dementia (AD/ADRD). After
dialysis initiation older (≥65) patients experience a 21-25% lifetime risk of AD/ADRD. Younger ESRD patients
experience premature cognitive aging requiring the study of cognition and AD/ADRD across the lifespan. Black
ESRD patients are more than twice as likely to develop cognitive impairment and 70%-78% more likely to be
diagnosed with AD/ADRD; this disparity is comparable to a 10 year increase in age. While systemic racism is a
known contributor to health disparities in community-dwelling older adults, its impact on cognitive aging among
ESRD patients is understudied. Measurement of systemic racism (i.e., structural, institutional, and
interpersonal) is crucial to identifying ESRD patients who are at risk of premature cognitive aging and those
who are resilient in the face of racism. Elucidating mechanisms by which systemic racism impacts cognitive
aging will lead to interventions and policies that may prevent the devastation of AD/ADRD for 234,000 Black
ESRD patients. We seek to address a National Institute on Aging (NIA) goal (RFA-MD-21-004): “To elucidate
whether and how mechanisms connecting structural racism to aging-relevant outcomes, including cognition
and AD/ADRD, operate on multiple levels.” ESRD patients are the ideal population to elucidate these
mechanisms: 1) 30% of patients are Black; 2) 87% experience premature cognitive aging; 3) all enroll in a
national registry and 65% in Medicare for measurement of institutional racism. For all adult ESRD patients in
the national registry/Medicare database, we will glean 23 indicators of structural racism from publicly available
data and identify 3 indicators of institutional racism. Then, we will link these data to our ongoing, NIA-funded,
multi-center, prospective cohort study (FAIR, n=5,275) of aging and ESRD to fully characterize systemic
racism (lifecourse structural racism, institutional racism, and interpersonal racism). This is the oldest (>12
years) ESRD cohort study that includes longitudinal measures global and domain specific cognitive function.
The National Kidney Foundation, Alzheimer’s Association, and a local community advisory board will guide the
design and interpretation of the following aims: 1) To estimate the impact of structural and institutional racism
on incident AD/ADRD; 2) To quantify the contributions of lifecourse systemic racism on cognitive impairment
and decline; and 3) To test whether resilience to systemic racism protects against cognitive impairment and
decline. By taking a lifecourse approach and engaging community, family, and patient stakeholders in all
phases of our study, we will identify feasible targets for improving resilience in the face of systemic racism.
These potential targets for interventions and policies to counter structural racism will likely generalize to other
populations with chronic diseases.

Public health relevance
PROJECT NARRATIVE Of the 170,000 older (≥50) kidney transplant (KT) recipients in the US, we have estimated that 19% experience post-KT cognitive decline, and up to 17% are diagnosed with dementia and Alzheimer’s Disease (AD). Air pollution is likely an important modifiable risk factor for post-KT cognitive aging. We seek to estimate the impact of air pollution on incident dementia/AD; these aims are supported by a comprehensive training program includes courses and mentorship on health equity, epidemiology, and gerontology and is designed to support the candidate as she becomes a clinician scientist.